PE in modulation of energy flux through OXPHOS

Project Summary - This document has not changed from the parent award.
Mitochondrial oxidative phosphorylation (OXPHOS) consists of a series of processes that takes place in the
inner mitochondrial membrane (IMM). Energy flux through OXPHOS appears to be intrinsically modulated by
the lipid composition of IMM by mechanisms that are not clearly understood. In particular, phosphatidyl-
ethanolamine (PE) is a cone-shaped non-bilayer lipid that induces membrane curvature in cristae and binds
with high affinity to mitochondrial respiratory complexes and regulate their functions. We found that
interventions that induce high OXPHOS flux are accompanied by increases in mitochondrial PE, and such
increase was sufficient to increase mitochondrial respiratory capacity. The central premise of this proposal is to
provide a comprehensive bioenergetics prognosis for altered mitochondrial PE content. Combining high-
resolution respirometry, fluorometry, electrophysiology, and microscopy, we will examine the role of PE in the
following processes: 1) Regulation of mitochondrial pyruvate entry at IMM to facilitate the Warburg effect, 2)
Origin of electron leak in the electron transport chain to induce oxidative stress, and 3) Efficiency of ATP
synthesis to alter cellular fuel economy.

Public health relevance
Project Narrative - This document has not changed from the parent award. Flux through oxidative phosphorylation is regulated by mechanisms that are not completely understood. The proposed research will address fundamental questions on how the lipid composition of mitochondrial membrane regulates bioenergetics. Findings from these studies have implications for health and disease across multiple organ systems.